Increasing organoid reproducibility and complexity for drug testing and disease modeling

Abstract
The failure of preclinical models to accurately predict cancer drug efficacy costs patient lives and slows the
development of new therapies. Most cancer drugs fail because they are not effective in vivo or are not targeted
to the appropriate patient population. Next generation tissue models that predict efficacy would therefore
advance drug development and provide personalized models of disease for patients who do not respond to first
line treatments. Patient Derived Organoids (PDOs) are an emerging next generation tissue model that self-
organize from human tumor cells. When sourced from appropriate clinical specimens and cultured in appropriate
three-dimensional (3D) environments they have demonstrated the potential to predict the efficacy of drugs in
both the preclinical and clinical setting. Modern clinical trials like I-SPY 2 are potential sources of such tumor
specimens that are associated with deep molecular profiling and information about clinical response. However,
applying these specimens to PDO for clinical and preclinical drug testing requires transformative improvements
in scalability, speed, physiological relevance, complexity, and reproducibility. We propose an approach called
“4D tissue fabrication” which provides such improvements. Central to our approach is guiding organoid self-
organization by careful consideration of the mechanics, chemical composition, and geometry of tissue interfaces.
To control these features we developed a new piezoelectric extrusion bioprinter that delivers organoid cell slurries
at tissue-like densities to specific 3D coordinates in hydrogel support baths carefully optimized for organoid self-
organization and growth. The result is organoids with dramatically more homogeneous size, morphology, and
phenotype. In a proof of principle drug response assay using 4D tissue fabrication we demonstrated a
nine order-of-magnitude improvement in statistical power compared to traditional organoid culture.
Here we propose to bring this enormous improvement in organoid uniformity to breast cancer PDOs derived
from tissue gathered during the I-SPY 2 clinical trial and from an ongoing UCSF breast biobanking effort. Our
proposal has three primary aims. First we will develop rapid, sensitive and reproducible platforms for screening
drugs in a preclinical setting. Second we will develop workflows to grow and assay PDOs from rare or slow
growing cell sources. Third we will optimize existing workflows to build more complex assays for DCIS organoids,
immune cells, and perfusable vasculature. Performance metrics are provided for all aims. If successful, we will
accomplish two important goals with significance to cancer patients: producing more sensitive and predictive
pre-clinical models for the development of new drugs targeting intractable cancers like subsets of Triple Negative
Breast Cancer, and producing clinical models of a patient’s own tumor with the potential to identify silver bullets
capable of targeting tumor types that suffer from low clinical response rates.

Public health relevance
Project Narrative Patient-derived tumor organoid models will revolutionize our ability to test drugs and understand cancer but have important limitations. We propose a generalizable approach to direct the rapid formation of more complex, reproducible, and functional human breast cancer organoids directly from a patient’s tissue. If successful, these models will provide personalized cancer models to identify the specific drug suited to a tumor’s unique vulnerabilities, as well as to identify new classes of drugs with increased efficacy and decreased toxicity.